Oncogenic Impact of eIF4E-dependent RNA Export in Cancer

Abstract
This renewal application investigates the impact of dysregulated RNA processing in cancer.
Dysregulation of these events can elevate the production of proteins that function in all facets of
malignancy, without altering their transcript levels. The eukaryotic translation initiation factor
eIF4E, dysregulated in many cancers including in acute myeloid leukemia (AML), governs the
RNA processing of networks of transcripts that ultimately underpin its oncogenic activities. Its
ability to govern these regulons has been attributed to its well-established roles in nuclear export
and translation of specific RNAs. eIF4E elevation in cancer patients is correlated with aggressive
disease and poor outcomes. Here, we discovered that eIF4E reprograms various facets of cell
motility including adherence, migration, and invasion through its effects on RNA processing.
Indeed, we identified eIF4E-dependent RNA export targets that encode factors which are key
modulators of cell motility including hyaluronan, its main receptor CD44 and ezrin. Ezrin is an
intracellular protein that links CD44 signalling to cytoskeletal changes that alter adherence,
migration, and invasion. Furthermore, eIF4E directly interacts with ezrin. Three aims are proposed
to dissect the mechanistic principles and biological impacts related to these novel findings. We
will uncover the requirements for eIF4E to drive cell movement, determine the role of the ezrin-
eIF4E complex in translation and motility, and examine the role of the HA/CD44/ezrin axis in
eIF4E-dependent AML cell motility in mouse models. Our studies provide a unique opportunity to
identify novel biochemical mechanisms that underpin aggressive disease associated with
dysregulated eIF4E.

Public health relevance
Project Narrative The protein, eIF4E, is important to normal cells and when dysregulated can drive the development of a broad array of cancers. eIF4E does this by co-opting the signal from the DNA (known as RNA) allowing it to generate more of the proteins that can drive cancer. In this proposal, we identified a new mechanism by which eIF4E uses this activity to imbue cancer cells with the ability to move, and thus invade neighboring tissue. We can exploit this new knowledge to ultimately develop new therapeutic strategies for high-eIF4E cancers.